RECOMBINANT RHU GM-CSF &HOTERICIN B VS AMPHOTERICIN B ALONE IN HIV INFECTION

The study will compare the duration of response in patients with oropharyngeal candidiasis to Amphotericin B alone versus Amphotericin B plus rhuGM-CSF in HIV patients.